Integrin Signaling Pathways in Prostate Cancer

DESCRIPTION (provided by applicant): Integrins comprise a large family of cell surface receptors with critical roles in cancer cell proliferation, invasion and metastatic potential. Experiments carried out during the last funding cycle have uncovered a novel pathway of prostate cancer progression mediated by the avβ6 integrin. We have found that avβ6 is not expressed in human and mouse normal prostate but becomes significantly upregulated in preneoplastic lesions, prostatic adenocarcinoma (AdCa) and bone metastasis. Mechanistically, avβ6 expression results in upregulation of androgen receptor (AR) activity via a JNK-mediated pathway. Our findings show, for the first time, that integrins modulate AR activity. In this pathway, we have identified survivin, a bifunctional regulator of cell division and inhibitor of apoptosis, as one of the critical downstream effector molecule which becomes upregulated in cells expressing avβ6. Our in vivo data demonstrate that expression of avβ6 results in enhanced tumor growth and metastatic dissemination as compared to a different av integrin, avβ3. Expression of avβ6 also causes tumor-mediated osteolysis, a crucial step in prostate cancer metastasis. Since avβ3 has been shown to promote bone gain in prostate cancer metastatic lesions, we hypothesize that the extent of bone-lesion formation is controlled by the relative expression levels of avβ6 and avβ3. Finally, we show that these integrins' expression is regulated by two different transcription factors activated by TGFβ: avβ6 is induced via Smad3 activation, whereas avβ3 expression is mediated by Runx2. We have formulated a unifying hypothesis that avβ6 integrin functions as an integrator of multiple signaling pathways to promote early and late phases of prostate cancer progression. This hypothesis will be tested in the present renewal application by the following aims. In Aim 1, the molecular mechanisms by which avβ6 activates AR will be investigated. In Aim 2, we will investigate in vivo the role of avβ6 in prostate cancer progression in a mouse model of prostate cancer; for this purpose, we will use the prostate specific Pten-null mouse model which develops PIN, cancer and metastasis. In Aim 3, to credential av integrins as molecular targets in prostate cancer bone lesion therapies, we will dissect the pathways by which avβ6 and avβ3 contribute to bone disease in vivo. Our long-term objective is to take advantage of this newly generated knowledge to develop novel molecular antagonists of prostate cancer progression. PUBLIC HEALTH RELEVANCE: Studies carried out during the last cycle have uncovered a key role of the avβ6 integrin in early and late stages of prostate cancer progression. We will dissect in the present application the pathways by which avβ6 enhance tumorigenesis and metastatic bone disease. In parallel, we plan to perform an in vivo study to investigate whether an antibody to avβ6 inhibits tumor progression in a mouse model of prostate cancer, Ptenpc-/-. This preclinical study in Ptenpc-/- mice, if successful, will pave the way for a clinical study which may help selecting patients with PTEN mutations {which represent approximately 50% of prostate cancer patients in the US} as the target patient population for avβ6 inhibitors. The pathways described in the present application are relevant to the human disease since prostate cancer accounts for a significant cancer burden in USA, where in 2008 it was projected to result in over 28,000 deaths and more than 180,000 new cases. Large gaps still exist in our understanding of disease progression, and this has hampered the development of more effective drugs. New therapeutic approaches in advanced prostate cancer are urgently needed, and harnessing the frequent molecular defects in prostate tumors, such as Pten deficiency, may provide innovative therapeutic opportunities. By inhibiting avβ6 - dependent signaling pathways, we will identify critical new approaches suitable for therapeutic intervention and pave the way for personalized therapies of prostate cancer. We will also gain insights in the mechanisms that promote bone metastasis, which is very frequent in prostate cancer patients and which results in severe bone pain, hypercalcemia, nerve compression and pathological fractures. Current treatments, chemotherapies, radiation and bisphosphonates all ameliorate components of the disease, but are not completely effective. Our long-term goal is to take advantage of our mechanistic studies to help develop novel molecular strategies for inhibition of prostate cancer progression in humans.

Public health relevance
NARRATIVE Studies carried out during the last cycle have uncovered a key role of the v6 integrin in "early" and "late" stages of prostate cancer progression. We will dissect in the present application the pathways by which v6 enhances tumorigenesis and metastatic bone disease. In parallel, we plan to perform an in vivo study to investigate whether an antibody to v6 inhibits tumor progression in a mouse model of prostate cancer, Ptenpc-/-. This preclinical study in Ptenpc-/- mice, if successful, will pave the way for a clinical study which may help selecting patients with PTEN mutations {which represent approximately 50% of prostate cancer patients in the US} as the target patient population for v6 inhibitors. The pathways described in the present application are relevant to the human disease since prostate cancer accounts for a significant cancer burden in USA, where in 2008 it was projected to result in over 28,000 deaths and more than 180,000 new cases. Large gaps still exist in our understanding of disease progression, and this has hampered the development of more effective drugs. New therapeutic approaches in advanced prostate cancer are urgently needed, and harnessing the frequent molecular defects in prostate tumors, such as Pten deficiency, may provide innovative therapeutic opportunities. By inhibiting v6 - dependent signaling pathways, we will identify critical new approaches suitable for therapeutic intervention and pave the way for personalized therapies of prostate cancer. We will also gain insights in the mechanisms that promote bone metastasis, which is very frequent in prostate cancer patients and which results in severe bone pain, hypercalcemia, nerve compression and pathological fractures. Current treatments, chemotherapies, radiation and bisphosphonates all ameliorate components of the disease, but are not completely effective. Our long-term goal is to take advantage of our mechanistic studies to help develop novel molecular strategies for inhibition of prostate cancer progression in humans.